COMMUNITY PROGRAMS FOR CLINICAL RESEARCH ON AIDS

The mission of the Terry Beirn Community Programs for Clinical Research on AIDS is to test, by scientifically sound methodology, interventions that are in wide use or of potential use [in HIV infection], in primary care settings, focusing on underserved populations, and emphasizing studies that assess clinical hypotheses with easily measured and clear clinical endpoints and that do not require specialized equipment or tests.